ACCOMPLISH (Applied Coaching of COMPutational Learners In Substance use and HIV) Mentoring Program

PROJECT SUMMARY/ ABSTRACT
Methamphetamine (MA) use has been increasingly recognized as a significant contributor to the worsening
health outcomes of individuals with HIV (PWH), with severe comorbidities including immune dysfunction,
cardiovascular disease, and pulmonary hypertension. Even in the presence of effective antiretroviral therapy
(ART) that maintains viral suppression, MA use exacerbates HIV pathogenesis and complicates efforts to
achieve an HIV cure. Despite the high prevalence of MA use among PWH, its direct effects on HIV cure efforts,
particularly how it alters HIV reservoirs and immune function, remain poorly understood. The overarching goal
of this proposal is to investigate the complex intersection of HIV, methamphetamine use, and immune
dysfunction. In addition, this career mentorship award will provide protected time for Dr. Lee to expand her
mentoring capacity of early-stage data science investigators in the interdisciplinary field of clinical translational
HIV and substance use research. This proposal outlines a comprehensive, data-driven approach to investigate
how MA exposure influences HIV reservoir transcription and host immune responses, with the goal of developing
computational models that can predict the biological consequences of MA exposure, and ultimately, inform HIV
cure strategies. The specific aims of this proposal will employ advanced statistical and computational methods
to examine the causal relationships between MA exposure and immune dysfunction, quantify the pharmacologic
effects of MA in individuals with HIV, and identify the genetic factors that mediate these effects. In Aim 1, we will
apply causal inference methodologies to longitudinal data from Dr. Lee’s ongoing Effect of Methamphetamine
on Residual Latent HIV Disease (EMRLHD) cohort. This analysis will focus on determining whether MA exposure
causally influences host immune dysfunction, including the activation of the NLRP3 inflammasome and elevated
IL-1β signaling, as well as whether it contributes to persistent HIV transcription in CD4+ T cells of individuals on
ART. In Aim 2, we will use pharmacokinetic/pharmacodynamic (PK/PD) modeling to explore the dose- and host-
specific effects of MA on HIV reservoir transcription and immune function. Using data from a randomized
placebo-controlled trial of PWH on ART receiving oral MA, we will apply nonlinear mixed-effects PK/PD modeling
to assess how varying doses of MA impact host immune responses (such as cytokine levels and gene
expression) and HIV reservoir transcription. Finally, in Aim 3, we will prioritize genes that are functionally relevant
to MA exposure using a transcriptome-wide association study (TWAS) approach, combined with machine
learning algorithms, integrating genetic data with transcriptome data to identify genes whose expression is
influenced by MA exposure. This work will address critical gaps in our understanding of how MA exposure impairs
immune function and maintains HIV reservoirs, even in individuals on ART. Ultimately, this work will not only
advance our understanding of MA’s role in HIV pathogenesis but also help lay the foundation for innovative,
data-driven therapeutic strategies to address both HIV and substance use comorbidities in the future.

Public health relevance
PROJECT NARRATIVE Methamphetamine (MA) use is common among people living with HIV and worsens their health, even when their HIV is controlled by medication. This research aims to understand how MA use affects the immune system and contributes to persistent HIV infection, despite effective treatments. Dr. Lee's work will use advanced data analysis to identify the biological mechanisms behind these effects, which could lead to better treatments for both HIV and substance use disorders, while also mentoring the next generation of researchers in this critical field.